Managing Obesity by Leveraging Health Information Technology to Lower Cancer Risk

Obesity is an important risk factor for many serious diseases including many types of cancer.2-36 In the
United States, obesity disproportionally affects underserved population groups such as racial and ethnic
minorities, persons with lower socioeconomic status, and persons living in rural areas.1,37,38 These underserved
groups are also at increased risk for developing and dying from cancer.39-42 Large clinical trials, such as Look
AHEAD (Action for Health in Diabetes), have shown that a multicomponent weight loss intervention combining
diet, physical activity, and behavioral modification is effective in achieving long term weight loss which resulted
in a lower incidence of obesity-related cancers.43-45 As a result, clinical practice guidelines recommend the
delivery of obesity interventions in primary care settings. However, it is unknown if such weight loss
interventions work well in underserved populations or in rural settings because of limited access to healthcare
resources and community facilities for a healthy lifestyle and/or because the target population may have
different cultural and social backgrounds.
To overcome these specific barriers to implementing a weight loss intervention, we propose a practice-
based clinical trial to translate the efficacious Look AHEAD Intensive Lifestyle Intervention (ILI) to underserved
populations. In this project, we will modify the intervention to be delivered through Health IT specifically the
patient portal in the electronic health record (EHR) and will work with the Methodist Medical Group to
establish partnerships between the investigators and community stakeholders. This project tests whether the
Look AHEAD Intensive Lifestyle Intervention (ILI) will result in significant weight loss when delivered through
Health IT- EHR patient portal compared to a Comparison intervention. This project will be conducted in 2
stages: a formative assessment stage (Stage 1) and a clinical trial stage (Stage 2). During Stage 1, we will
modify the interactive technology-based Look AHEAD ILI that we already developed for the TARGIT study
(Active Intervention Group). We will also adapt the Look AHEAD Comparison condition (DSE group) for our
Comparison condition.56 We will also optimize the protocol for acceptability in underserved populations and in a
rural setting. During Stage 2, we will randomly assign 250 participants to either the Comparison Group or the
Active Intervention Group to address the primary aim of testing the hypothesis that a multicomponent,
behavioral weight loss intervention delivered through Health IT – EHR patient portal will lead to significantly
greater weight loss 12 months after enrollment compared with a comparison group. Our Health IT-based
intervention is potentially cost-effective and thus disseminable to any practice-based physician group with
access to an EHR with a patient portal. We have chosen the Socio-ecological Model as our conceptual model
to assist with understanding social determinants of health as related to the study intervention and weight loss.

Public health relevance
The proposed project will develop and conduct a randomized clinical trial for weight loss, using Health IT – EHR patient portal in underserved populations (racial / ethnic minority populations, lower socioeconomic populations, rural populations). The results of the proposed project will help inform patients, healthcare providers, and public- and private-sector health plans on how to treat obesity in underserved populations in primary care settings using the Health IT - EHR patient portal which may prevent cancer.